Biogenesis of the gram-negative bacterial cell envelope

PROJECT SUMMARY
The outer membrane in Gram-negative bacteria is a dynamic interface that mediates bacterial
interactions with the host by displaying proteins on its surface. The recently discovered surface-
exposed lipoproteins (SLPs) play critical roles in pathogenesis, including iron and nutrient
acquisition, adhesion, immune evasion, and serve as valuable vaccine targets. Despite their
biomedical importance, the mechanism underlying lipoprotein localization to the cell surface is
the least understood aspect of bacterial envelope biogenesis. The long-term goal of research in
my laboratory is to define the mechanism of lipoprotein targeting and export to the bacterial cell
surface. Improving our understanding of the molecular determinants for export will enable the
development of predictive computational models for lipoprotein localization and genomic
identification of SLPs. One SLP subfamily includes lipoproteins that depend on a partner β-
barrel outer membrane protein (OMP) for surface exposure. We discovered the RcsF lipoprotein
in Escherichia coli as the first example of this type. Furthermore, we discovered that the highly
conserved and essential β-barrel assembly machinery (Bam) complex plays a critical role in the
biogenesis of RcsF, uncovering the novel function of the Bam complex in lipoprotein biogenesis.
Here, we propose to use an interdisciplinary approach to identify the molecular mechanism by
which the Bam complex displays lipoproteins on the cell surface. For in-depth mechanistic
investigations, we continue our work in E. coli, focusing on how the Bam complex recognizes
SLPs and coordinates lipoprotein surface exposure with OMP assembly and the specific role of
Bam lipoproteins in this process. However, we are also expanding the scope to include other
gram-negative model systems to facilitate studies of conserved and variable aspects of
envelope and SLP biogenesis, enriching our understanding of these processes across diverse
species. Completing the proposed studies will substantially expand our understanding of the
biogenesis of SLPs and, more broadly, Gram-negative cell envelope biogenesis. The
knowledge gained from the proposed studies will enable the formulation of computational
models for identifying novel SLPs and much-needed vaccine targets.

Public health relevance
PROJECT NARRATIVE Recently discovered surface-exposed lipoproteins (SLPs) in Gram-negative pathogens play critical roles in pathogenesis and are proven vaccine targets, but their biogenesis is poorly understood. This project seeks to determine the mechanism of lipoprotein targeting and export to the cell surface to enable the computational prediction of SLPs. The knowledge gained from the proposed studies will aid in identifying novel vaccine targets necessitated by the rise of antibiotic resistance in Gram-negative pathogens.